Advancing molecular fluorescence-guided surgery platform

ABSTRACT
This Academic-Industrial Partnership (AIP) will further the clinical development of fluorescence guided surgery
(FGS) through the utilization of the FDA exploratory Investigational New Drug (eIND) pathway. While recent
advances in both imaging agents and technology for FGS has been impressive, significant limitations remain in
detecting low dose administration of imaging agents and obtaining true molecular contrast between the tumor
and normal surrounding tissues. The basis of this application and the underlying tenet of the proposed AIP is
that a cost-effective, risk-diluted approach to clinical translation of imaging methodologies is needed in order to
realize the promise of FGS. Utilization of our previously developed bench-to-clinic pipeline stands to accelerate
surgical oncology to revolutionize both the procedures that are possible and the surgical outcomes that will result.
In the first funding cycle our AIP implemented a low-cost testing pipeline for ABY-029, a fluorescent epidermal
growth factor receptor-targeted synthetic peptide. We established the necessary protocols to bring ABY-029
from pre-clinical animal models into three Phase 0 clinical trials using the FDA eIND pathway (eIND #122681).
We will build upon our previous success to apply for Investigational New Drug (IND) status of ABY-029 for
economical, investigator-led Phase II testing of detection accuracy in glioma and head and neck cancers. Sim-
ultaneously, we will utilize the pipeline to achieve eIND approval of paired-agent imaging. The proposed AIP
between Dartmouth (Engineering and Medical Schools), Affibody AB, LI-COR, and DoseOptics brings together
4 partners who have the intellectual property (IP), expertise and infrastructure to develop, test and advance
molecular-targeted fluorescent tracers and imaging systems for surgical guidance.
Clinical translation and testing of FGS will be achieved through the completion of the following aims:
Aim 1 - Advance near-microdose ABY-029 FGS for resection of primary high-grade glioma in a Phase 2 trial;
Aim 2 - Adapt FGS system for minimally invasive resection of head and neck cancers for Phase 2 testing; and
Aim 3 - Leverage the Dartmouth fluorescent agent development pipeline to bring quantitative molecular paired-
agent imaging (PAI) to Phase 0 trial using a cocktail of ABY-029 and IRDye 680LT carboxylate (pABY-IR680).
The translational INNOVATION will include advancement of ABY-029 into Phase II clinical trials, first-in-human
implementation of paired-agent imaging for true molecular contrast via the established bench-to-clinic eIND pipe-
line, and the integration of a highly sensitive, multi-channel near infrared surgical camera imaging system capa-
ble of imaging in full surgical lights. The SIGNIFICANCE of this AIP will be to demonstrate improved margin
detection for surgical resection of glioma and head and neck cancers using a low-cost, efficient testing pipeline.

Public health relevance
NARRATIVE This proposal will expand upon a developed industrial partnership platform (Affibody AB, LI-COR Bio- sciences, Inc. and Dartmouth Engineering & Oncology) for the bench-to-clinical translation of an EGF- receptor targeted fluorescent peptide via the FDA exploratory investigational new drug pathway. The utility of this pipeline will be demonstrated by testing efficacy of tumor detection in Phase II trials for both primary high-grade glioma and head and neck cancers, and translating a paired-imaging agent drug product, which improves the efficiency and the efficacy of fluorescence guided surgery. In addition, DoseOptics will join the industrial partnership to develop much needed imaging instrumentation with high sensitivity to near-microdose levels of fluorescent agents in full surgical lights.